Environmental stress and epigenetic repression in the developing embryo

Project Summary
Epidemiological and experimental evidence suggest that early life exposure to environmental stress can
have long-term health consequences. Epigenetic changes represent one mechanism linking prenatal
exposures to latent health outcomes. However, despite the clear

Public health relevance
Project Narrative Developmental exposure to environmental stresses including heavy metals, endocrine disrupting agents and DNA damage can cause adult-onset disease, and is therefore a significant public health problem. Completion of this research is expected to broaden our understanding of the epigenetic mechanisms that link early-life exposures to disease and to improve the assessment of public health risks associated with diverse environmental stressors.